Developing a wearable medical device to detect opioid overdose

Project Summary
This proposal is submitted in direct response to PA-25-212 Innovation Corps (I-Corps™) at NIH Program for NIH
and CDC Translational Research (Admin Supp Clinical Trial NOT Allowed). Persons of all ages with Opioid Use
Disorder (OUD) are at risk for opioid overdose, which can cause Opioid Induced Respiratory Depression (OIRD),
leading to hypoxia and death. Most overdose deaths in the U.S. occur without anybody else present, preventing
bystander administration of the lifesaving drug naloxone. Technology to detect OIRD and issue an emergency
signal could help ensure responders arrive at the scene of an overdose to administer naloxone in a timely
fashion. Currently, there are no FDA-approved products to detect opioid overdose or OIRD that are designed for
continuous wear in a discreet location on the body.
Resilient Lifescience’s goal is to develop a wearable medical device that can detect OIRD and issue an
emergency alert, calling a friend, loved one, or emergency medical service to the scene.
The hypothesis for this I-Corps project is that this lifesaving overdose detection technology can be marketed
directly to family members of individuals with OUD, and that doctors prescribing opioids to patients with elevated
risk for OIRD will be interested in co-prescribing monitoring technology.
The objective of this I-Corps research is to conduct customer discovery activities in order to validate, refine,
and/or redefine Resilient Lifescience’s business model, which is based on the above hypothesis. This will be
completed by conducting interviews with (1) users of prescribed and illicit opioids and their loved ones (2)
physicians that prescribe opioids, specifically in states with naloxone co-prescription laws, and (3) industry
stakeholders relevant to the distribution and financing of opioid patient safety products, such as health insurance
leaders, state opioid response teams, and more.

Public health relevance
Project Narrative The objective of this I-Corps proposal is to conduct customer discovery research to validate, refine, or redefine the commercialization plan for the Resilient Monitor. The Resilient Monitor is an investigational medical device to detect Opioid Induced Respiratory Depression (OIRD). In 2022 there were over 80,000 fatalities from opioids and an estimated 83% of those deaths occurred without a bystander present to administer the lifesaving drug naloxone. This technology stands to benefit people who use prescribed or illicit opioids alone by detecting a life- threatening overdose and calling for a first responder.